METHODS FOR POSITIVE AND NEGATIVE SELECTION OF HEMATOPOIETIC PROGENITOR CELLS

Preclinical development of automated closed system methods for positive and negative selection of lymphohematopoietic cells have been done in collaboration with biotechnology firms which have developed systems for potential application to clinical cellular therapies. A. Baxter Isolex: Over 50 preclinical evaluations were carried out with the Isolex 300SA system for immunomagnetic positive selection of CD34+ hematopoietic progenitor cells. These evaluations accomplished the requisite development and validation of this methodology prior to incorporation into a clinical trial of gene therapy for chronic granulomatous disease (PI, Harry Malech). Current studies are focusing on development and validation of the new Isolexi, the improved, more automated version of this system. In ongoing studies of this device, we are processing granulocyte colony-stimulating factor (G-CSF) mobilized normal donor leukapheresis collections and evaluating the yield of CD34+ cells, the depletion of CD3+ T cells, and the overall utility of the system. Results of this evaluation, and comparison with evaluations of other systems (see below), will determine its applicability for specific clinical trials. B. CellPro T Cell Depletion system: A preclinical evaluation of this 2- step positive (CD34) and negative (CD2) selection system, which uses an immunoadsorption approach, was recently completed. For eight GCSF- mobilized leukapheresis products from normal donors, mean depletion of CD3+ T cells was 3.75 logs, and mean CD34+ cell yield was 44%. This system is ready for incorporation into clinical trials of allogeneic T-depleted hematopoietic transplantation after required regulatory applications to FDA. These results will also be evaluated in relationship to those from the ongoing Baxter Isolex system evaluation (see above).